RNA regulation in germline development and fertility

Our research team explores genetic, molecular, and cellular interactions between germ
cells and somatic (non-germline) cells of the gonad. We focus on the mechanisms
regulating reproductive system formation and function. Key questions are: 1) how are
germline stem cells (GSCs) established and why are they absent in women? and 2)
what establishes and maintains the sex-specific identity of germ cells, gonadal and
extragonadal somatic cells, all of which are required for reproductive success and
species perpetuation. Our goal in pursuing this research program is to define the
developmental mechanisms regulating gonadogenesis to prevent infertility and to
extend reproductive opportunities and choices for women and their partners. Extending
reproductive potential is not only central to population preservation and fulfilling dreams
of parenthood, it will also mitigate or eliminate health risks that accompany premature
ovarian failure, perimenopause, and menopause in many women. From a
developmental perspective, disorders of sexual development (DSDs) are common, and
include gonadal dysgenesis, dysregulated puberty, gender dysphoria, and sterility,
thereby posing challenging sex-specific treatment decisions. DSDs are idiopathic or
result from genetic or hormonal anomalies during sexual development. With humans
living longer and delaying parenthood, declining reproductive potential and increased
germline mutation burden affect all sexes. We will leverage powerful genetic tools, cell
imaging, and genome-wide multi-omics approaches to unravel the cellular and
molecular underpinnings of reproductive development, health, and fertility, largely
neglected areas of biomedical research.

Public health relevance
Germ cells are essential for fertility. Our long-term goal is to understand the mechanisms that regulate specification and maintenance of the germline. The immediate goal of our research is to investigate the function and contribution of conserved genes to stem cell specification and sex-specific development of the germline, which has implications for understanding normal reproductive development, Disorders of Sexual Differentiation, and fertility, areas of biomedicine greatly in need of more research.